POP: 09/28/2019-09/27/2020 CLINICAL SITE AND STUDY MONITORING FOR RESEARCH PARTNERSHIPS FOR GLOBAL MENTAL HEALTH.

The Contractor shall provide comprehensive clinical site and study monitoring services for the NIMH/ORDGMH CHIRMH clinical trials.